Facilitating Alcohol Screening and Treatment (FAST), Colorado

Project Summary – FAST, Colorado Alcohol use causes an estimated 88,000 deaths yearly and is the third leading cause of mortality in the U.S. Unhealthy alcohol use, a spectrum from risky drinking to alcohol use disorder (AUD), impacts 27% of adults, with high cost to the health care system. Evidence-based guidelines exist for identification and treatment of unhealthy alcohol use, and evidence supports the effectiveness of medication-assisted therapy (MAT). Primary care is recognized as an ideal context for the implementation of screening and treatment processes. Despite the evidence, significant gaps exist in uptake into practice. Practice facilitation has emerged as a key method for assisting practices in implementing organizational changes and improvements. However, in-person practice facilitation is time-intensive and costly, and virtual facilitation has not been as effective as in-person. E-learning modules can provide a structure for quality improvement in a clinical area. A pilot using e-learning combined with virtual practice facilitation was very successful from the perspectives of both practice facilitators and practices. We believe that virtual practice facilitation using e-learning modules to focus the content and process has great potential as a less costly and equally effective method compared to in-person facilitation. In this “Facilitating Alcohol Screening and Treatment (FAST) Colorado” proposal, we would perform a cluster randomized trial to examine the Reach, Effectiveness, Adoption, Implementation, Maintenance (RE-AIM) and relative value of two approaches to supporting primary care practices to implement PCOR findings to improve their identification and treatment management of unhealthy alcohol use among adults, including screening, brief intervention, medication assisted therapy, and referral to treatment. This trial would investigate the non- inferiority from an effectiveness perspective and the superiority from a cost perspective of: a) a virtual practice facilitation intervention, with a practice facilitator working with practices in virtual group sessions utilizing an alcohol use disorder e-learning module to guide and focus the process and content, when compared to b) an in-person practice facilitation intervention. We would identify key practice characteristics and other contextual factors that impact the response of practices to the two practice interventions. We would compare the adaptability, trialability, and scalability of the two interventions in order to plan dissemination of the findings to key local, regional, and national stakeholders, including sharing ongoing lessons learned and resources with other programs supporting practice transformation.

Public health relevance
Project Narrative – FAST, Colorado Alcohol use is the third leading cause of death in the United States. Primary care practices need to implement new research findings that help identify and treat alcohol use disorder. This project would compare two methods of supporting small and medium size primary care practices in Colorado to improve their alcohol screening and treatment.